Supplement to Neurobiological Engineering Training Program

SUMMARY
The mission of the NBETP is to train early-mid stage graduate students to become future leaders
at the interface between neurobiology and engineering. This is accomplished via a blend of
course requirements in neuroscience and engineering, including several dedicated neurotech-
nology classes, as well as through mentorship and community-associated events that encourage
student leadership and career development. Students admitted into the program are selected
based on intellectual caliber, leadership potential, commitment to neurobiological engineering
research, willingness to take on risky and potentially game-changing projects, and diversity. Stu-
dents are engaged in innovation of emerging bioengineered technologies that enable fundamen-
tal biological discoveries with translational potential related to a broad spectrum of neurobiolog-
ical diseases including neuropsychiatric and neurological conditions, as well as addiction. Goals
of the program are thus very well aligned to the objectives of NIBIB-funded T32 grants and to
the mission of NIBIB overall, and they also synergize with interests of ICs such as NIMH, NINDS,
and NIDA. An administrative structure oversees the training program's direction, student admis-
sion, and assessments. Preceptors associated with the NBETP include a set of faculty with di-
verse, multidisciplinary expertise encompassing multiple departments and intersection of multi-
ple traditional disciplines such as bioengineering, electrical engineering, chemistry, and neuro-
biology. The program thus closely fits the profile of a “broad-based NRSA training program,” as
described in NOT-EB-07-005. Funding currently provides for four predoctoral students to partic-
ipate in the program for two years each. In its first five years, the program has attracted a diverse
set of trainees and offered them important and enriching experiences during and after their
funded periods. The program has also contributed to substantial research and leadership ac-
complishments by individual trainees, as well as to significant expansion of the footprint and
visibility of neuroengineering research and education at MIT and beyond. In the next five years,
if our renewal application is supported, we will have exciting opportunities to enhance the pro-
gram, develop further experiences for our trainees, and begin to observe outcomes following
graduation of our first cohorts of trainees. We hope that the program can be renewed with further
funding from the NIH, and we are confident that the program can continue to offer outstanding
benefits to our trainees and to the broader community.

Public health relevance
NARRATIVE The mission of the NBETP is to train early-mid stage graduate students to become future leaders at the interface between neurobiology and engineering, a frontier highlighted by the Federal BRAIN Initiative and critical in the ongoing quest to understand the brain and its diseases. Training in neurobiological engineering is accomplished via a blend of course requirements in neuroscience and engineering, as well as associated activities that encourage student participation, leadership, and career development.